Utilizing All of Us data to examine the impact of COVID-19 on mental health among people living with HIV

Abstract
In response to the NOSI (NOT-PM-22-002), we propose to expand the resilience conceptual framework in
our parent grant (1R01MH127961-01A1, 12/2021-11/2026) to a different context (COVID-19) and a new
population (people living with HIV [PLWH] in the United States). Further, we propose to explore if a resilience
approach can be used to mitigate the negative impacts of COVID-19 on the mental health among PLWH. We
will leverage multiple datasets from the All of Us program, including electronic health records (EHR), a series
of COVID-19 Participant Experience (COPE) surveys, and other self-reported survey data. Integrating these
data from about 12 thousand PLWH who participated in COPE, we will: 1) examine the trends and patterns of
mental health outcomes (i.e., psychiatric disorder diagnoses via ICD-10 and mental health assessments via
survey) among PLWH before and after the COVID-19 outbreak; and 2) identify protective factors at multiple
socioecological levels including the individual level (e.g., resilience), interpersonal level (e.g., social support),
and health institutional level (e.g., health service accessibility) that may mitigate the negative impacts of the
COVID-19 pandemic on mental health outcomes among PLWH, especially the subgroups with socially
disadvantaged status (low income and low education) and stigmatized identities (racial/ethnic minorities,
sexual and gender minorities). Based on rich data from a large cohort of PLWH, the findings will advance our
understanding of their mental health needs during the pandemic and mental health disparities of PLWH in the
US and inform tailored health interventions to improve mental health outcomes among PLWH, especially
those from disadvantaged subgroups. Our study goal is aligned with the Office of AIDS Research's and National
Institute of Mental Health's research priorities in terms of social sciences studies and health disparities
reduction. The proposed study will leverage existing NIH investment, capitalize on a rapid understanding of
mental health needs among PLWH, stimulate additional collaborations with the All of Us program, and
promote the translation of All of Us data to public health implications. The experience and preliminary data
obtained from this supplement will position us for further efforts in utilizing All of Us data to improve mental
and other health outcomes of PLWH in the US.

Public health relevance
Project narrative The COVID-19 pandemic has imposed numerous mental health challenges upon people living with HIV (PLWH) and exacerbated existing mental health disparities among PLWH in the United States by income, education, race/ethnicity, and sexual and gender identities. To foster a deeper understanding of their unique mental health vulnerabilities during the pandemic and to develop effective interventions to promote mental health for PLWH, we need to comprehensively investigate trends and patterns of mental health outcomes among PLWH before and after COVID-19 outbreak and also identify protective factors for PLWH, especially those from various disadvantaged subgroups. Leveraging rich data extracted from a large cohort of PLWH in the All of Us program, the proposed study has the potential to advance our knowledge of the mental health needs of PLWH during the pandemic and inform tailored intervention strategies that can increase resilience, reduce disparities, and improve the psychosocial wellbeing of PLWH.